IRF4-dependent T-cell effector programs in governing transplant outcomes

Project Summary
Solid organ transplantation is a lifesaving treatment for patients with end-stage organ failure, but long-
term allograft survival is limited by immune rejection and side effects of immunosuppressive drugs.
Allogeneic T cell responses are central to transplant outcomes (rejection versus tolerance). It is thus
essential to define the T cell effector programs that affect the transplant outcomes.
We recently discovered that interferon regulatory factor 4 (IRF4) is a key transcriptional determinant
controlling allogenic T cell response in transplantation. IRF4 deletion in T cells results in progressive
establishment of CD4+ T cell dysfunction and long-term cardiac allograft survival. These findings have
been accepted for publication in Immunity. Herein, we hypothesized that IRF4 governs transplant
outcomes through controlling the core regulatory circuits of T cell function. Therefore, the central focus
of this proposal is to identify the IRF4 controlled regulatory circuits in alloreactive effector T cells.

Public health relevance
Project Narrative The success of organ transplantation is limited by T cell-mediated transplant rejection and side effects of immunosuppressive drugs. Our project is aiming to uncover the T cell effector programs that govern the transplant outcomes, which may have important clinical implications.